Data Archiving for a Decade-Long View of HIV in Young Adulthood

PROJECT SUMMARY
Tsogolo La Thanzi (TLT) is a decade-long NICHD-funded population-based cohort study of young women and
men from Balaka, Malawi. TLT has followed young adults (ages 15-25 at enrollment, 15-35 inclusive) as they
navigate relationships and childbearing within the context of a generalized AIDS epidemic. TLT enrolled more
than 3000 individuals and collected 11 waves of data, covering a 10-year period (2009-2019) that spans
massive changes in the HIV treatment context in Malawi as well as the ages of peak incidence and peak fertility
for female respondents. Due to the high sampling fraction, circumscribed geographic setting, and extremely
detailed data on affiliations, behaviors, and characteristics, these data are sensitive and vulnerable to risks of
deductive disclosure.
TLT data collected between 2009-15 have already been made publicly available via Data Sharing for
Demographic Research (DSDR). The intent of this proposal is twofold: 1) to make the latest round of TLT data
(fielded in 2019) accessible to the research community while protecting respondent confidentiality and 2) to
strategically recruit and support new data users in public health and the social sciences. In collaboration with
experts at NICHD-supported Data Sharing for Demographic Research (DSDR), the TLT study team will deposit
two valuable data sources (local census and survey), accompanied by high-quality documentation to guide
scholars in their proper use. Moreover, the study team will create a toolkit for new and potential data users to
support the community of TLT data users by sharing code for data analysis. The team will also lead outreach
efforts to recruit new data users from beyond the original study team, with a focus on supporting new users
from low-income contexts. Organized around the aims of data archiving (Aim 1), quality documentation (Aim
2), and data promotion (Aim 3), this proposed project seeks to enhance the scientific impact of the TLT study
and broaden the knowledge underpinning research and policy with respect to the changing nature of HIV,
fertility, mortality, marriage, education, and technology use that characterize Balaka, Malawi, and also much of
sub-Saharan Africa.

Public health relevance
PROJECT NARRATIVE This application outlines a plan to archive two new datasets collected by the Tsogolo La Thanzi project (TLT) in Balaka, Malawi. Following the release of ten waves of data collected between 2009 and 2015, yet another census and survey were collected in 2019; the 2019 data are uniquely valuable because they feature new modules on kinship, mental health, and trust in clinics and because they facilitate analysis of a full ten years of social change in Balaka township and across the life course. Our intent is to 1) make the full ten-year span of TLT data accessible through the Data Sharing for Demographic Research initiative, 2) provide clear and careful documentation in order to facilitate the appropriate use of TLT data by new users, and 3) broaden the impact of the NICHD-funded TLT study on research and policy related to HIV, fertility, health, and transitions to adulthood.